CARDIAC MORPHOLOGY AND FUNCTIONAL CHANGES INDUCED BY EPIRUBICIN

Cardiac functional studies were made and endomyocardial biopsies were obtained on 24 patients who received epirubicin in total cumulative doses arranging from 180 mg/m(2) to 918 mg/m(2) for the treatment of neoplasm. A total of 20 biopsies were evaluable. Histologic and ultrastructural changes were similar to those caused by other anthracycline agents. A strong correlation was demonstrated between total dose of epirubicin and pathologic change as quantified using the Billingham scale (r = 0.7, p = 0.0006). Patients who are expected to receive epirubicin in excess of 450 mg/m(2) should be based on the results of monitoring.